Localization and function of tissue type 2 lymphocytes during mixed inflammation

Project Summary/Abstract:
Type 2 allergic immunity is a specialized subtype of immune response that limits multicellular helminths and
protozoa. However, recent work also implicates type 2 immunity in physiologic tissue remodeling, which in
excess can drive allergy, asthma, atopy, and tissue fibrosis. Type 2 immunity is coordinately driven by tissue
type 2 innate lymphoid cells (ILC2s) and type 2 CD4+ T helper cells (Th2s). Tissue-resident ILC2s and Th2s
have a high degree of transcriptional and functional similarity, secreting high levels of the cytokines IL-5 and IL-
13 to organize downstream immune and non-hematopoietic cells. Although diverse tissue signals regulate these
cells, it remains unclear how their broad localization (i.e. topography) within organs is controlled and how this
may impact immune pathology. In many tissues, ILC2s and Th2s localize to fibroblast-rich adventitial areas
around larger blood vessels and lung airways. Our preliminary data show that type 2 inflammation drives their
expansion into de novo parenchymal niches (e.g. near alveoli in lung, hepatocytes in liver). We find that ILC2s
require trafficking-associated pathways to expand into parenchymal niches, whereas type 1 lymphocytes (T1Ls)
are broadly distributed in tissues and produce IFNγ+ that confine ILC2s and Th2 subsets to adventitial niches. In
models of mixed type 1/type 2 inflammation, enforced ILC2s and Th2s in parenchymal sites inhibit effective T1L-
mediated responses leading to increased mortality. Our central hypothesis is that ILC2 and Th2 localization to
tissue parenchymal niches occurs via trafficking from blood pools and must be tightly controlled to balance
immune risks and benefits to organs. Aim 1 will define the mechanism(s) and impact of IFNγ repression of ILC2
and Th2 cell parenchymal distribution. We will test the hypothesis that IFNγ produced by T-cells restricts cell
trafficking into parenchymal niches during mixed inflammation. We will use genetic tools to eliminate IFNγ-
signaling on ILC2s and Th2 subsets and determine functional consequences in models of mixed inflammation.
Aim 2 will determine the routes and signals that control ILC2 and Th2 parenchymal localization. Here we will
test the hypothesis that type 2 immunity activates tissue type 2 lymphocyte expansion and ‘retrograde trafficking’,
with transitory residency in the blood allowing for tissue-specific re-entry in parenchymal sites and ultimate type
2 niche expansion. We will use multimodal approaches, including organ transplantation, photoconversion,
parabiosis, and cell transfers to determine the required trafficking molecules, kinetics, dwell time, and ultimate
fate in parenchymal sites. Aim 3 will define functional impacts and targets of ILC2 and Th2 parenchymal
localization. Here we will test how production of IL-13 and other signals target discrete tissue immune and stromal
subsets, potentially impairing effective type 1 immunity and leading to context-dependent beneficial or pathologic
outcomes. Successful completion of the proposed work will provide fundamental mechanistic data on how tissue
topography of ILC2s and Th2s impacts function, laying the groundwork for future diagnostic and therapeutic
approaches that can direct type 2 localization to impact beneficial and pathologic immune responses.

Public health relevance
Project Narrative This study will determine how the location and movement of a subset of white blood cells associated with ‘allergic immunity’ controls their function, ultimately regulating organ damage and repair. We will determine how these cells move from their homes in resting organs to new sites during inflammation, and how this ‘niche spread’ can be limited to impact organ physiology and pathology.